Pharmacokinetic and pharmacodynamic assessment of peptide-based therapy DA1 for the treatment of Alzheimer's disease

PROJECT SUMMARY/ABSTRACT
JanusQ, LLC is a startup biotech company, spun out of Case Western Reserve University, and developing
a peptide-based therapy for treatment of mitochondrial dysfunction in Alzheimer’s Disease (AD), which is
eroding the memory and cognitive abilities of ~6 million Americans. The role of amyloid-β (Aβ) in AD
pathogenesis is poorly understood, and therapies addressing A have not been successful in the clinic. The
observation that, like many other neurodegenerative diseases, AD is linked to mitochondrial dysfunction that
leads to neurotoxicity suggests a novel strategy: ATAD3A is a mitochondrial protein that spans both inner and
outer membranes and is critical in cholesterol trafficking and maintaining the mitochondrial nucleoid complex.
However, during the stress of AD, ATAD3A oligomerizes and binds Drp1 (the mitochondrial-fission GTPase),
causing mitochondrial fragmentation and nucleoid instability. DA1, a peptide newly discovered by a JanusQ
cofounder, prevents ATAD3A oligomerization and association with Drp1, reduces mitochondrial fragmentation,
improves nucleoid stability, and reduces behavioral and neurological deficits in rodent models of AD and
Huntington’s disease. However, little is known about the disposition and dose-dependence of DA1 in vivo. Thus,
it is difficult to know whether unmodified DA1 is already suitable as a clinical candidate for the treatment of AD,
or whether future work will be required to optimize the peptide to improve its pharmacological characteristics
(potency, absorption, distribution, elimination). The purpose of this SBIR grant is to make that determination.
The project has three aims: (1) Assess the pharmacokinetics of DA1 in vivo to test exposure and stability by
developing approaches to extract DA1 from plasma and brain tissue, collecting samples at various time points
after administering the peptide subcutaneously (SQ), and quantitating the peptide using tandem liquid
chromatography mass spectroscopy. (2) Perform preliminary in vitro safety/toxicity assessment of DA1, focusing
on discovery-phase assays, with an assessment of potential off-target interactions and immunogenicity. (3)
Assess DA1 dose-response characteristics using an in vivo AD mouse model, treating APP knock-in AD mice
(aged 3–9 months) initially with three DA1 doses SQ. Validation assays will assess ATAD3A oligomerization,
mitochondrial bioenergetics, measures of AD pathology(e.g., Aβ accumulation, synaptic integrity, neuronal loss),
and cognitive function during AD development. These results will directly address our central hypothesis that
DA1 has the pharmacological properties necessary for advancement to the clinic (vs. future peptide
optimization). Thus, the proposed work is the next logical step toward the long-term goal of developing a peptide
therapy to improve quality of life and survival of AD patients. Such a treatment would reduce reliance on medical
caregivers and thus reduce overall medical costs. In the US, direct medical costs alone exceeded $305B in 2020.
This SBIR grant is a crucial step for JanusQ to develop DA1 per se (or first to optimize DA1) as a breakthrough
treatment for AD. Either approach would put JanusQ in a position to attract a commercialization partner.

Public health relevance
PROJECT NARRATIVE JanusQ, LLC is a startup biotech company, developing a novel drug to treat Alzheimer’s Disease by preventing key proteins in mitochondria from inappropriately binding to each other, and thereby causing dysfunction of nerve cells in the brain. In mice, the drug markedly improves the course of the disease , leading to improved long-term memory and cognition. This grant will allow JanusQ to determine whether this drug—as handled by the body—is already suitable for more advanced studies, or whether the drug first will require optimization.